Muscle-driven, implanted endoprostheses for musculoskeletal limb reconstruction

PROJECT SUMMARY
The long-term goal of the proposed translational project is to improve the sensorimotor function of people with
amputation and other severe musculoskeletal defects. Physically attaching muscles to limb prostheses could
restore natural motor and sensory function to patients. Since all prostheses must be worn externally on the
body, the previous approach required transferring muscle forces through skin, which had limitations in function
and appearance. To better facilitate physical muscle-prosthesis attachment, the proposed project introduces
endoprostheses, which are jointed limb prostheses that can be completely implanted within living skin. The
geometry and mechanical properties will likely differ between endoprosthetic and biological limbs, and
endoprostheses may be implanted at different times across clinical cases. There is an urgent need to
understand how the endoprosthesis and muscle reattachment timing affect muscle structure and motor
function. The overall objective of the proposed project is to determine the effects and interactions of muscle
reattachment timing (immediate vs delayed) and context (biological vs endoprosthetic limb) on muscle
structure and motor function in a rabbit model of below-knee amputation. The project’s central hypothesis is
that muscle structure and motor function will recover with delayed reattachment across an endoprosthetic
ankle but will be best when reattached immediately across a biological ankle. The rationale for the proposed
research is that it will provide critical in vivo data to support our future research and inform how
endoprostheses are implemented clinically. Phase 1 of the project includes two aims: (Aim 1) quantify the
effect of reattachment timing on muscle structure and motor function in a biological limb context, and (Aim 2)
determine the effect of muscle reattachment context (biological vs endoprosthetic limb) on muscle structure
and motor function. In Phase 2, Aim 3 is to evaluate the interaction effect of reattachment timing and context.
The endoprosthesis will replace the rabbit hindlimb ankle and foot, and muscles in the residual limb will be
attached across the endoprosthetic ankle using synthetic tendon. Muscle structure will be measured by
ultrasound imaging, tissue measurements, and histology. Motor function will be assessed by measuring
hindlimb biomechanics during locomotion and ankle force-generating capacity during electrical stimulation of
muscles attached to the endoprosthesis. The expected outcomes of the proposed research are a working in
vivo experimental platform – an MDE prototype and animal model – data on muscle structure and motor
function for different reattachment timings and contexts. The endoprostheses concept is highly innovative and
radically different from existing externally worn limb prostheses. Endoprostheses are significant because they
will enhance sensorimotor function and make limb prostheses more attractive, comfortable, and convenient to
use, drastically improving patients’ independence and quality of life.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it introduces a new, alternative, and potentially more effective solution for musculoskeletal reconstruction following amputation and other severe musculoskeletal defects. It is expected that the proposed endoprosthesis will facilitate physical muscle- prosthesis attachment to restore near-normal control and sensation movements, drastically improving patient function and quality of life. Thus, the proposed research and technology are directly aligned with the NIAMS mission to support research into the treatment of musculoskeletal diseases, including testing of orthopedic devices and implants.